Defining the Disease-Causing HRasG12V Mutation as a Link for Defective Myelin and Subnormal Learning

PROJECT SUMMARY/ABSTRACT
Formation, maintenance, and/or modification of myelin is necessary for high order brain functions including
learning, but it is still unclear whether myelin defects contribute to the onset of neurological conditions including
Learning Disabilities (LD), Attention Deficit and Hyperactivity Disorder (ADHD), and Autism Spectrum Disorders
(ASD). As genetic factors are believed to contribute to the onset of these conditions, the overall goal of this study
is to define molecular links for defective myelin/myelination and subnormal learning and memory in a monogenic
disease. Two myelin-centered mouse models of Costello Syndrome (CS) will be used as: CS is caused by mu-
tations in a single gene (HRas); CS patients present with high predisposition to develop LD, ADHD, and ASD in
correlation with abnormal myelin and White Matter (WM); and CS mouse models mimic diverse patient pheno-
types. To test the hypothesis that a CS mutation impairs motor skill learning by disturbing the function and the
timely/accurate formation of myelin, HRasG12V mutation will be induced in Oligodendrocytes (OLs; myelin pro-
ducing cells) and OL Precursor Cells (OPCs) at strategic time points. Preliminary results support that HRasG12V
in pre-existing OLs impairs learning of fine motor skills. Hence, Aim1 involves defining cell-autonomous/non-cell-
autonomous mechanisms regulating this learning phenotype, particularly those linked to increased nitric oxide
(NO) signaling. The Aim 2 will define changes in basal and learning-induced myelination, and functional connec-
tivity upon HRas mutation in OPCs of the developing and adult brain. This study is original and innovative as it
can impact our general understanding of brain function/dysfunction; it will be first in establishing developmental
and chronic roles of HRas as the link for defective myelin and subnormal learning. Drugs studied used here -
targeting glial NO - can diversify and expedite the development of treatments for CS and associated conditions.
Finally, experimental evidence obtained will help settle the long-lasting debate on the links between abnormal
myelin and the neuropathophysiology of RAS/MAPK pathway-related diseases (RASopathies).
The PI’s expertise is in in vivo glial pathways and behavioral analyses and has been productive in RASopathy
research. To establish a solid research program and become competitive for NIH R01 funding, training goals
include attaining expertise in myelin biology, learning brain-wide research approaches (fcMRI, high-volume brain
imaging), and acquiring a clinical perspective of RASopathies. Therefore, the mentoring team includes 1) a pio-
neer scientist in myelin biology (~30 years in the field), 2) an expert/innovator in rodent MRI brain analyzes, 3) a
leading clinician in RASopathies, and 4) a prosperous intramural scientist to guide the PI’s tenure promotion.
The planned research and training were designed to promote the PI’s independence and to be foundation for an
R01 application aimed toward defining myelin-regulated behaviors upon germline HRas mutation. Additionally,
obtaining collaborations and preliminary data for electrophysiological analyses, behavioral tests of ADHD and
ASD, and transcriptional and epigenomic analysis, among others, are scheduled in the period of support.

Public health relevance
PROJECT NARRATIVE The brain White Matter (WM) and its characteristic component myelin have emerged as active participants of the brain plasticity necessary for high order functions including learning and memory; consequently, WM/myelin disruption cause multiple neurological issues and it is believed to underly neurodevelopmental conditions includ- ing Learning Disabilities (LD). To discover the links between subnormal learning and defective myelin, I use mouse models of Costello Syndrome (CS), a neurodevelopmental disease caused by mutations in a single gene (HRas), in which most patients present with LD in correlation with WM/myelin abnormalities. Preliminary results indicate that myelin defects caused by a CS mutation negatively impact the ability of mice to learn fine motor skills; therefore, this project aims to describe cellular, molecular, and brain connectivity abnormalities underlying subnormal learning.